Admin Core

PROJECT SUMMARY
The goal of this Phase 2 COBRE for Computational Biology of Human Disease (CBHD) is to strengthen, expand,
and sustain research programs focusing on computational approaches to the basic biology of human diseases.
This involves support for faculty investigators that increases their competitiveness for peer-reviewed funding, as
well as support for resources and infrastructure that enhances Brown’s broader biomedical research community.
A key theme of this Center is to build upon the strengths of biomedical researchers whose individual questions
may differ widely, but whose underlying analytical questions share common ground in computational analyses
of large-scale genomic datasets that lead to discovery. The Administrative Core will lead, coordinate, and
manage 1) the general activities of the Center including strategic planning, advisory committee meetings, fiscal
accountability, regulatory compliance, communication, and reporting; 2) the career development activities of the
junior investigators including the Research Projects and Pilot Project programs, mentoring activities, and the
Computational Biology Core resource, and 3) activities that strengthen program sustainability including strategic
partnerships, program integration, community building, program evaluation, and cost-center planning. The
Administrative Core in Phase 2 will build upon the resources and infrastructure developed and implemented in
Phase 1 with proven effectiveness. Brown University has invested heavily in facilities that generate data (e.g.,
the Genomics Core), the Center for Computation and Visualization (CCV) that maintains the super computer
and staffs the Advanced Research Computing group that supports high performance computing, and research
centers with targeted academic interests in biology and medicine. Our CBHD COBRE is distinct from research
centers as the sole service Center focused on analysis of omics-enabled data. We will achieve the goals of
strengthening and sustaining the COBRE in Phase 2 with the following Specific Aims. 1. Provide scientific
leadership, administrative coordination, and fiscal management to support the continued integration, expansion
and strengthening of the Center. 2. Provide junior faculty Project Leaders with research funding, career
development mentoring, and computational resources to strengthen research competitiveness and achieve
peer-reviewed, sustainably funded research programs. 3. Facilitate and ensure Center sustainability and
responsiveness by integrative community building, establishing strategic collaborative partnerships, and
responding to formative and summative program evaluation.